TOXICOLOGY AND PHARMACOLOGY OF ANTICARCINOGENIC AGENTS

Expedite the development of new anticarcinogenic agents. These studies will be linked in large measure to other projects in biological and chemical prevention of carcinogenesis programs, which will provide the agents to be investigated and the means for testing agents for efficacy in anticarcinogenesis.